Clinical Trials with Immunotoxins

HA22 is licensed to Medimmune and been given the name Moxetumomab pasudotox. It is being tested in patients with chemo-resistant hairy cell leukemia (HCL) in adults and acute lymphoblastic leukemia in children. The HCL trial is a phase 3 trial to gain FDA approval for the drug. In ALL a phase 1 trial has been completed in which there was about a 30% response rate in children with refractory disease. A phase 2 trial has now been initiated. For mesothelioma therapy we have been testing immunotoxin SS1P in combination with Pentostatin and Cytoxan and observed major prolonged responses in several patients with advanced mesothelioma. We are also carrying out a phase 1 trial with a new clinically optimized de-immunized immunotoxin (RG7787) in collaboration with Roche. The trial has just opened. Trials with LMB2 targeting CD25 in Acute T Cell Leukemia have just been completed and several durable complete responses were observed in patients with refractory disease. R. Kreitman is the lead investigator in those trials.